Examining Social Ecological and Network Factors to Assess Epidemiological Risk in a Large National Cohort of Cisgender Women

PROJECT SUMMARY
While HIV prevention strategies have improved and HIV incidence rates continue to decrease in the United
States (US), a critical need remains to strengthen and advance prevention science where declines appear to
have stalled, particularly among cisgender women of color. The most recent surveillance data from the Centers
for Disease Control and Prevention demonstrate that as of 2019, about 7,000 of all new HIV diagnoses were
identified among cisgender women (hereafter simply referred to as “women”). Traditional demographic and
behavioral risk factors are insufficient to identify women who are vulnerable to HIV infection. Recent research
on the use of risk algorithms to determine pre-exposure prophylaxis (PrEP) eligibility demonstrated poor
predictive power for women in contrast to good predictive value among men who have sex with men.
Identifying women who are vulnerable to HIV infection is crucial for the development and deployment of
tailored prevention approaches. While the mode of HIV acquisition for women is well known, with heterosexual
contact (85%) identified as the most frequent mode of HIV transmission among women, followed by 15% due
to injection drug use, less is known about the social-ecological factors (e.g., community, network, geospatial,
and policy factors) associated with HIV seroconversion. Broadly, several factors beyond individual behavior
have been associated with increased risk for HIV acquisition among women in the US such as gender
inequality, income, exposure to domestic and sexual violence, homelessness, and sex partner’s
characteristics. Nonetheless, identifying the combination of characteristics that predict seroconversion among
women and establish them as candidates for PrEP has been challenging. To overcome this gap and in
response to RFA-AI-21-058, we propose to harness innovative digital methods to establish a knowledgebase
for women living in the US who are behaviorally vulnerable to HIV. The knowledgebase will consist of a
national cohort of 1,800 women from whom we will collect HIV and sexually transmitted infections (STIs)
incidence data and social and sexual network data, paired with open-source big data to contextualize HIV risk
among women vulnerable to HIV infection. Our study team has extensive experience in using digital
approaches to recruit study participants (through electronic methods and geospatial analytics). Capitalizing on
our expertise, we will use the developed knowledgebase to identify theoretically-driven correlates of HIV
seroconversion, STI incidence, and predictors of PrEP uptake. Findings will increase our understanding of
women’s vulnerabilities to HIV infection, enhance identification of PrEP eligibility, and inform interventions to
decrease the incidence of HIV and STIs among women living in the US.

Public health relevance
PROJECT NARRATIVE Cisgender women account for approximately 20% of annual HIV diagnoses in the United States; yet, there is limited information on the combination of factors that contribute to HIV incidence in these women. In response, our study team proposes to develop a knowledgebase of integrated data including biomarker data from a cohort of cisgender women behaviorally vulnerable to HIV infection paired with network data and big data from disease surveillance and social determinants of health databases. At the conclusion of the knowledgebase construction and the cohort and network analysis, we will have identified individual, social network, geospatial, and public policy factors that increase a women’s risk for HIV and/or sexually transmitted infection acquisition, providing intervention opportunities to reduce women’s vulnerabilities to HIV infection.